IAA-NCEA/EPA-0001; “Chemoinformatics of EPA’s EDSP Universe of Chemicals”

Chemoinformatic support for HTS data studies include, an update of Tox21 QSAR models using chemical descriptors. A collection of chemical features (Saagar) are being develoed for a list of transparent, diverse and easily updatable structural descriptors that can be used for many different NTP projects that involve QSAR modeling projects and read-across analysis.